Mechanism of Sleep Regulation by SIK3

Project Summary
Sleep and metabolic disorders are often comorbid, but how they interact is poorly understood. The salt
inducible kinase SIK3 was identified (first in C. elegans and 8 years later in flies and mice) as a sleep drive
regulator. Our findings suggest that SIKs connect sleep and metabolic regulation. In the prior funding cycle, we
demonstrated hierarchical somatic/neural interactions regulating both sleep and energy homeostasis. We have
shown that the sleep and energy-regulating roles of KIN-29/SIK occur by inhibiting the class 2 histone
deacetylase HDA-4 (HDAC4) in 12 pairs of glutamatergic neurons. Illuminating the mechanism by which KIN-
29 signals in glutamatergic neurons during high sleep drive will be the goal of aim 1. We will study the role of
CREB and CREB-regulated transcription coactivator 1 (CRTC1) in glutamatergic neurons. In aim 2, we will
test the hypothesis that reactive oxygen species promote sleep. In aim 3 we will test the hypothesis that NAD+
precursors promote sleep and are reduced in kin-29 mutants. Finally, in aim 4, we will identify genes whose
expression is regulated by the KIN-29--|HDA-4 signaling module. Such genes will be candidates for mediating
sleep-promoting signaling by glutamatergic neurons. At the completion of these aims, we will have an
improved understanding of the genetic and metabolic regulation of sleep. Data collected in aim 4 will motivate
additional genetic hypotheses that will be tested in future research.

Public health relevance
Project Narrative Disorders of sleep regulation frequently occur in individuals with disorders of metabolism, but the relationship between the two is not understood. Our research focuses on a particular mechanism that links sleep regulation with metabolic regulation.